In silico safety pharmacology

PROJECT SUMMARY: A major factor plaguing drug development is that there is no drug-screening tool that
can distinguish between drugs that will induce cardiac arrhythmias from chemically similar safe drugs. The
current approaches rely on substitute markers such as action potential duration or QT interval prolongation on
the ECG. There is an urgent need to identify a new approach that can predict actual proarrhythmia from the drug
chemistry rather than relying on surrogate indicators. We have brought together an expert team to innovate at
the interfaces of experimental and computational modeling disciplines and develop an in silico simulation pipeline
to predict cardiotoxicity over multiple temporal and spatial scales from the atom to the cardiac rhythm.
An essential and unique aspect of our approach is that we propose to utilize atomistic scale simulation to predict
the transition rates of ion channels and adrenergic receptors and how they are modified by drug interaction. We
hypothesize that it is the subtleties of these interactions that are likely to be the critical determinants of drug
associated safety or proarrhythmia. In the last award period, we successfully developed an unprecedented
linkage: We connected the highly disparate space and time scales of ion channel structure and function. We
utilized atomistic simulation to compute drug kinetic rates were directly used as parameters in a hERG function
model. The model components were then integrated into predictive models at the cell and tissue scales to expose
fundamental arrhythmia vulnerability mechanisms and complex interactions underlying emergent behaviors.
Human clinical data were used for model validation and showed excellent agreement, demonstrating feasibility
of this new approach for cardiotoxicity prediction. In this renewal application we propose to hugely extend this
approach to include prediction of the interaction of cardiac channel gating and drug interaction as well as the
inclusion of adrenergic receptor interactions with drugs. Another essential aspect of safety pharmacology is the
development of new approaches to allow more efficient drug design, screening and prediction of cardiotoxicity.
Therefore, we will seek to develop, extend and apply a variety of machine learning and deep learning approaches
to improve drug discovery by predicting proarrhythmia from the drug chemistry with an efficient process that
identify drug congeners via machine learning to maximize therapy and minimize side effects. Finally, we propose
to classify drugs into categories based on proarrhythmia risk in normal and diseased virtual tissue settings. The
multiscale model for prediction of cardiopharmacology that we will develop in this application will be applied to
projects demonstrating its usefulness for efficacy or toxicity of drug treatments in the complex physiological
system of the heart.

Public health relevance
PROJECT NARRATIVE: Cardiotoxicity in the form of deadly abnormal rhythms is one of the most common and dangerous risks for drugs in development. There is an urgent need for new approaches to accurately screen and predict the effects of drugs on cardiac rhythms. Our team proposes a new computer-based model framework to predict drug effects from the level of the atom to the cardiac rhythm.